Leadership, Planning & Evaluation

LEADERSHIP, PLANNING, AND EVALUATION – PROJECT SUMMARY/ABSTRACT
The University of Virginia Cancer Center (UVACC) is led by a Director and seven Associate Directors. These
individuals work individually and together with each other and the Senior Leadership Group and the CCSG
Executive Committee to advance the goals of the UVACC. These individuals and committees manage program
planning and evaluation as a continuous and deliberate process.
External guidance is provided by the External Advisory Board, which provides the UVACC with strategic and
organizational advice, and the Community Advisory Council, which guides the UVACC to ensure a focus on
cancer health equity across the catchment area. In parallel, the UVACC relies on internal monitoring and
feedback to determine how to best implement these practices to advance its goals. This external-internal
dynamic ensures a planning and evaluation process that generates Program changes; strengthens basic,
translational, clinical, and population research leadership and infrastructure; provides new and improved
Shared Resources; encourages collaborations; influences community outreach and engagement; guides
training and mentorship activities; and implements recruitments.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.